Imaging Core

C o r e B : The Imaging Core will perform all MR and bioluminescence imaging studies on mouse tumor models for Projects 1 and 2. In addition, the Imaging Core is responsible for all preclinical and clinical data archiving, post-processing and analysis. Core personnel will provide services including: (a) define and implement data acquisition/imaging sequences; (b) assist with animal preparation for imaging; (c) perform all data collection on the 9.4 Tesla MRI, 7 Tesla MRI and Caliper bioluminescence imaging systems; (d) preliminary data processing/image reconstruction and quantitative analysis including PRM analysis for both preclinical (Projects 1 and 2) and clinical imaging data (Project #3) and outcomes data; (e) secure archival of raw data and network transfer of reconstructed data from off-site facilities; (f) scheduling of imaging experiments; and (g) provide support to Program Investigators in technical design and implementation of imaging experiments. These services are designed, in part, after a